Immuno-modeling in human colorectal cancer: linking in vitro immunotherapy responses with multiparameter characterization

Project summary
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
24-029.
For colorectal cancer (CRC), the efficacy of current immunotherapies like checkpoint inhibition has been
disappointing, and scores of new strategies are being developed to bolster efficacy by targeting the numerous
features of the TIME that can impede robust and lasting anti-tumor immune responses. However, we have
little understanding of which features dominate the response to any given class of immunomodulators
since they all work together in complex ways and we don’t have retrospective patient data to probe since
most of these are not yet in clinical trials. Our overall goal here is to understand how various patient-
specific features of colorectal cancer (CRC) and its tumor-immune microenvironment (TIME) govern
differential responses to different types of immunotherapies using our novel in vitro ‘avatars’ of the tumor-
immune circuit (‘TIvitars’) that we developed in our parent grant. To accomplish this, we are partnering with
clinician-scientist Prof. Ben Shogan, who runs a CRC biobank and collects corresponding stool samples for
microbiome analysis. We will establish and perform immunotherapy screens using human CRC tissues
from 20 patients comparing responses of each tumor to a broad range of immunomodulators that can (a)
compare efficacy among numerous therapies for each patient’s tumor in a response-predictive way, and
(b) correlate these responses with the molecular and cellular characteristics of each tumor (obtained from
standard -omics analysis of the samples) as well as with the patient’s microbiome (obtained from
sequencing stool samples). We hypothesize that by interrogating multiparameter -omics data and clinical
data using immunotherapy responsiveness data collected using TIvitar, we will identify tumor-intrinsic
features that contribute to immunotherapy responsiveness in CRC patients.
In Aim 1, we will systemically characterize each patient’s tumor, gut microbiota, and systemic
immune status. For each patient, we will determine dominant tumor mutations, tumor gene expression
patterns, characteristics of the immune infiltrate, stromal features, systemic immune status, and microbiota
populations from fecal samples collected prior to surgery. In Aim 2, we will use TIvitar to determine each
patient’s response to a screen of different immunomodulators. In Aim 3, we will pair the immune response
data with the -omics data collected in Aim 1 to identify shared tumor, immune, or microbiota features that could
predict susceptibility to immunotherapy. The resulting data will form a completely unique dataset whereby
standard -omics data from cancer patients will be coupled with differential immunotherapy responses for
each.

Public health relevance
Project Narrative Our overall goal is to understand how various patient-specific features of colorectal cancer (CRC) and its tumor-immune microenvironment (TIME) govern differential responses to different types of immunotherapies using novel in vitro ‘avatars’ of the tumor-immune circuit (‘TIvitars’) that we developed as the first aim of our parent grant. To accomplish this, we will establish and perform immunotherapy screens using human CRC tissues from 20 patients comparing responses of each tumor to a broad range of immunomodulators that can (a) compare efficacy among numerous therapies for each patient’s tumor in a response- predictive way, and (b) correlate these responses with the molecular and cellular characteristics of each tumor (obtained from standard -omics analysis of the samples) as well as with the patient’s microbiome (obtained from sequencing stool samples). The resulting data will form a completely unique dataset whereby standard -omics data from cancer patients will be coupled with differential immunotherapy responses for each.